2021 Annual Educational Conference (AEC) and Exhibition Three-Part Virtual Series

Project Summary/Abstract The National Environmental Health Association (NEHA), a 501(c)3 nonprofit organization, is pleased to submit an application for funding assistance under the U.S. Food and Drug Administration (FDA) Support for Conferences and Scientific Meetings (R13 Clinical Trial Not Allowed), FOA Number: PAR-19-306. Due to the COVID-19 pandemic, social distancing, shelter-in-place orders, and the cancellation of local conferences, meetings, and events, environmental health (EH) professionals are finding it increasingly difficult to obtain access to continuing education and training. In response, NEHA’s 2021 Annual Educational Conference (AEC) & Exhibition Three-Part Virtual Series being held on April 20–21, June 1–2, and July 14–15 aims to fill this need. This conference is designed to train, educate, and advance EH professionals, as well as bring people together to build a network of EH colleagues, exchange information, and discover new and practical solutions to food safety issues during a pandemic. The AEC Three-Part Virtual Series will address new research findings and practical approaches to food safety during a crisis with the goal to build capacity for attendees to apply new knowledge, skills, and abilities in their organizations and agencies. The AEC meets the needs of those who have a specialty, such as food safety, and generalists who provide a broader scope of EH services. EH professionals have been on the frontline of an unprecedented pandemic. COVID-19 brought with it changes to roles and increased responsibilities. The 2021 AEC will bring together EH professionals to share experiences, research, expertise, and best practices as we work together for a safer and healthier tomorrow. NEHA requests funding assistance to develop, administer, and conduct this three-part virtual series. NEHA anticipates an estimated cost of $600,000 for the 2021 AEC Virtual Series and is requesting assistance in the amount of $50,000. NEHA requests funding to assist with virtual platform associated costs and audio/visual costs to provide high quality education and training to meet the needs of EH professionals. The vision of FDA’s Office of Regulatory Affairs that “all food is safe?and the public health is advanced and protected,” as well as its mission to protect consumers and enhance public health by maximizing compliance and minimizing risk aligns with NEHA’s mission to “build, sustain, and empower an effective environmental health workforce.” Both missions are embodied in the proposed virtual educational series.

Public health relevance
Project Narrative Due to the COVID-19 pandemic, social distancing, shelter-in-place orders, and the cancellation of local conferences, meetings, and events, environmental health (EH) professionals are finding it increasingly difficult to obtain access to continuing education and training. The 2021 Annual Educational Conference (AEC) & Exhibition Three-Part Virtual Series aims to provide the necessary continuing education to EH professionals. The virtual series will address new research findings and practical approaches on food safety during a crisis with the goal to build capacity for attendees to apply new knowledge, skills, and abilities in their organizations and agencies. The National Environmental Health Association (NEHA) is programmatically equipped with extensive experience in developing virtual just-in-time training modalities, formats, educational tools, and resources to better serve the needs of the EH workforce. NEHA’s 2021 AEC Virtual Series will provide a means to translate field-based research into action on retail food safety and other EH topics. The 2021 AEC Virtual Series is designed to meet the needs of both those who specialize in an EH area, such as food safety, as well as generalists who have broad responsibility in providing EH services. The purpose of the AEC is to build the capacity of EH professionals and their organizations to perform essential functions, solve problems, and define and achieve objectives. The three-part series will target its training modules toward EH professionals working at state, local, territorial, and tribal agencies. Attendees will learn how EH professionals are working with multiple agencies, industries, and levels of government to ensure the safety of the public and environment, and to further advance food safety.